US Association for the Study of Pain Annual Scientific Meeting

Pain continues to be a significant health care problem because of its prevalence, its impact on
those who suffer, and the absence of consistently effective therapeutic options devoid of
deleterious consequences. These issues will only be compounded with the aging of the US
population and the increased incidence of pain in those over 60 years old. Any progress in
addressing this growing problem will take a concerted effort from the basic scientists diligently
working to understand pain mechanisms to the health care providers struggling to manage pain
in their patients with limited tools and resources. It not only takes a sustained effort from those
already working to address this problem, but from subsequent generations of pain scientists as
well. The US Association for the Study of Pain (USASP) was formed to address these issues
and continues to develop ways of doing so. One of our solutions to push pain science forward is
an annual scientific meeting organized to facilitate the dissemination of the last advances in pain
science and the multidisciplinary discussion of these advances, as well as the career
development and mentoring of pain scientists and health care providers with a focus on early
career scholars. To maximize our ability to achieve these goals, the USASP and the scientific
meeting are organized around principles of diversity, equity and inclusion, where all interested in
addressing the complex problem of pain are welcomed to participate. The present application
seeks to secure support for trainees to attend the USASP annual scientific meeting in 2023, to
be held in Durham, NC, on the campus of Duke University. Consistent with the broader goals of
the USASP for the scientific meeting, the Specific Aims of this proposal are to 1) Provide a
national forum for conference attendees to discuss pain research findings that shape the
direction of the field, 2) Foster interdisciplinary dialogue and collaboration between researchers
representing multiple pain science disciplines in to develop innovative translational strategies to
address current challenges in pain research, and 3) Enhance communication between pain
science stakeholders (researchers, policy makers, clinicians, and patients) and both junior and
senior researchers to provide mentoring and build bridges between different pain science
communities. As the connections made early in a career pay dividends over the long term, we
seek support for 60 trainees to participate in this conference, building a foundation that will
ultimately lead to safe and effective pain management in the future.

Public health relevance
Pain continues to be a significant health care problem because of its prevalence, its impact on those who suffer, and the absence of consistently effective therapeutic options devoid of deleterious consequences. To begin to address this problem, the USASP will hold an annual scientific meeting that serves to facilitate dialog and interactions of pain scientists, health care providers and patients, disseminate and implement the latest findings, and facilitate the development of the next generation of pain scientists. As the connections made early in a career pay dividends over the long term, support for early career pain scholars is desperately needed to ensure safe and effective pain management in the future.